Developmental PBDE exposure, gut microbiome, and diabetes

PROJECT SUMMARY

Diabetes is a pandemic, causing grave social and economic burdens. This complex disease is caused by an
interaction among genetic, metabolic, behavioral, and environmental factors. Epidemiology studies and animal
experiments demonstrate that developmental exposure to the persistent environmental toxicants
polybrominated diphenyl ethers (PBDEs) is associated with increased diabetes prevalence and persistent
diabetic phenotype in adulthood. However, mechanisms governing early life PDBE exposure and the
diabetogenic phenotype remain unknown. Current literature supports the mechanistic link between gut
microbiome and metabolic syndrome in humans and animal models. We showed that oral exposure to PBDEs
in adult mice results in dysbiosis with profound changes in bacteria known to be associated with inflammation
and obesity, as well as reduced tryptophan microbial metabolites including indoles, which are novel activators
of the host pregane X receptor (PXR) which is known to contribute to obesity and diabetes. Building on our
findings that there is a gene-­environment interaction between PXR and PBDEs through gut microbiome and
indole metabolites, we seek to establish a causal relationship between developmental PBDE exposure, a
change in the gut microbiome, and diabetes later in life using humanized PXR transgenic (hPXR-­TG) mice in
conventional (CV) and germ-­free (GF) background. We hypothesize that developmental PBDE exposure
causes acute and persistent dysbiosis, which contributes to diabetes through suppression of microbial
tryptophan metabolism and selective PXR modulation (sPXRm) in early life and beyond. To test our
hypothesis, in Aim 1 we will determine if developmental PBDE exposure perturbs the gut microbiome and
microbial metabolism of tryptophan, leading to sPXRm in early life and beyond. In Aim 2 we will determine
whether microbial metabolites, mainly including indoles and indole-­derivatives, can reduce inflammation and
rescue the diabetic phenotype following developmental PBDE exposure. In Aim 3 we will determine that
reprogramming the gut microbiome using fecal transplant mechanistically contributes to developmental PBDE
exposure mediated disruption of PXR signaling and delayed onset of diabetes. The expected outcome of the
proposed research is a new research paradigm demonstrating that dysbiosis of the gut microbiome
mechanistically contributes to early life PBDE exposure-­induced diabetes and metabolic syndrome later in life,
and more importantly, enables a toxico-­metagenomics approach targeting metabolic disorders resulted from
exposure to PBDEs and potentially other persistent organic pollutants.

Public health relevance
PROJECT NARRATIVES Diabetes is a complex disease is caused by an interaction among genetic, behavioral, and environmental factors. The persistent environmental chemicals polybrominated diphenyl ethers (PBDEs) are linked to diabetes in humans and animal models. The proposed study will use humanized mouse models to mechanistically investigate how early life PBDE exposure mediated dysbiosis modulates host receptor signaling and contributes to delayed onset of diabetes phenotype in adulthood, paving the path for identifying novel “druggable” targets within the gut microbiome to reduce PBDE-induced persistent adverse health effects in humans.